Enhanced Soft Tissue-to-Bone Healing via Treatment with Novel Growth Factor NELL-1: Targeted Delivery and Biomimetic Scaffolds

I am an Orthopaedic Sports Medicine specialist pursuing a career as a clinician-scientist
focusing on the biology of soft tissue healing to bone. The comprehensive training plan
described in this proposal will uniquely position me as a surgeon-scientist to i) investigate the
biology of soft-tissue-to-bone healing, ii) characterize novel approaches for growth factor
delivery and scaffold design, iii) perform preclinical assessments of potential therapies and,
ultimately, iv) design and operate appropriately powered clinical trials aimed at improving the
treatment of soft tissue musculoskeletal injuries.
There are 32 million musculoskeletal injuries in the United States annually of which 45% involve
tendons or ligaments. Complete tendon and ligament separation injuries do not heal back to
their bony attachments without surgical intervention and, thus, are often treated with surgical
procedures including rotator cuff tendon repairs and anterior cruciate ligament reconstructions.
There are more than 5.7 million people with a rotator cuff tendon tear in the US alone and this
number is increasing as our population ages. In addition, there are more than 200,000 ACL
injuries in the US each year; the incidence of these injuries in the military population is ten times
higher than that of the civilian population. Normal tendon and ligament insertions to bone are
comprised of a complex tissue structure that effectively transmits the interactions between
dynamic muscle tissues and the rigid skeleton. Unfortunately, surgically repaired tendon tears
and ligament reconstruction procedures characteristically “heal” with an abnormal tissue
architecture that results in inferior biomechanical properties resulting in high failure rates. In this
proposal we aim to stimulate local progenitor cells to repair the enthesis via a novel approach by
delivering bisphosphonate-targeted growth factors to the bony site of the ruptured enthesis
coupled with the insertion of a uniquely-designed biomimetic scaffold embedded with those
factors.
The CDA award would provide me the opportunity to turn potential into results. In order to
accomplish the aims of this proposal we have assembled an internationally-recognized
mentoring team to provide me with the technical training required for this research. In parallel
with my mentored technical training, instruction in career development, drug discovery, data
analysis and translational aspects relevant to my research goals will be provided via the UCLA
CTSA-sponsored Training Program in Translational Science modules and supplemental
graduate school course work. With guaranteed protected time, institutional financial support
from my Department and 500 square feet of independent laboratory space and with
transdisciplinary, cross-specialty guidance provided by my mentorship committee, my scientific
advisory panel and my team of collaborators to assist in my development into an independent
translational scientist, The ultimate goal is to allow me to successfully i) compete for additional
VA, NIH and DoD grant funding, ii) manage a laboratory and iii) concurrently navigate a career
that flourishes at both the benchtop and the bedside.

Public health relevance
Despite the hundreds of thousands of tendon repairs and ligament reconstructions performed each year in the United States, clinically there is still no effective strategy to regenerate the complex tissue organization of native tendon and ligament attachments to bone (the enthesis). The goal of this proposal is to; 1) compare the efficacy of targeted delivery of biologically relevant growth factors BMP-2 and NELL-1 to promote enthesis regeneration; and 2) develop novel biomimetic scaffolds that facilitate local delivery of these factors in an environment that has favorable micro-mechanical enthesis-like properties. It is anticipated that these innovative approaches to the fundamental problem of enthesis generation will shift the current paradigm of treating musculoskeletal soft tissue injuries.